Mechanisms and Targeted Therapy of NRF2-high Esophageal Squamous Cell Carcinoma

PROJECT SUMMARY
This diversity supplement to the funded “Mechanisms and Targeted Therapy of NRF2high Esophageal
Squamous Cell Carcinoma” (R01CA244236) will expand the scope of the funded grant to study how levels
of reactive oxygen species (ROS) governs global kinase activity in ESCC. In the parent grant, we are
characterizing the molecular and phenotypic consequences of NRF2 hyperactivation in ESCC, determining
the mechanisms of action and efficacy of NRF2 small molecule inhibitors, and identifying NRF2-responsive
kinases and their functions in NRF2-driven ESCC biology. As a complement and extension of this work, the
proposed diversity supplement fills a void not studied in the parent project—the role of reactive oxygen
species in the regulation of kinase activity and kinase signal transduction in ESCC. This supplement will
support Dr. Emily Zarbock’s career development, giving her new scientific skills in cancer cell biology,
molecular biology and signal transduction. Dr. Zarbock is an expert in analytical chemistry and mass
spectrometry, and new expertise in cancer cell biology will enhance her academic career as she builds her
independent research program. In the proposed project, Dr. Zarbock aims to: 1) quantify ROS levels and
dynamics in ESCC human cell lines grown in 2D and in 3D as spheroids 2) identify Redox-sensitive
kinases in ESCC and 3) determine the role of select redox-sensitive kinases on ESCC signal transduction
and cell biology. Dr. Zarbock will work to connect reactive oxygen species to kinases, which while being
increasingly appreciated, has not been comprehensively studied or examined in ESCC model systems.

Public health relevance
Esophageal squamous cell carcinoma (ESCC) is prevalent in the world with a 5-year survival rate around 18%. Using human cells and animal models, we will characterize the molecular consequences of NRF2 hyperactivation in ESCC, determine the mechanisms of action and efficacy of NRF2 inhibitors, and find NRF2- responsive kinases and their functions in NRF2-driven ESCC biology. If successful, this work will help develop targeted therapy of NRF2high ESCC in human patients.